Plasma-Generated Hydroxyl Radicals for Analysis of Three-Dimensional Structures in Protein Therapeutics

Abstract The biological function and physicochemical properties of protein-­based therapeutics are determined by their higher order structures (HOS). Therefore, it is imperative to analyze the three-­dimensional higher order structure of protein therapeutics at several stages of the drug development process to ensure both safety and efficacy of the drug. Biopharmaceutical manufacturers are required to demonstrate the consistency of the protein HOS conformation to the regulatory agencies. Moreover, Identifying the binding site of a protein to its corresponding antigen (known as epitope mapping) is critical for the development of new therapeutics, vaccines and diagnostics. Food and Drug Administration (FDA) guidelines require specific binding site information between a drug and its target for the regulatory filing. Current techniques for protein HOS characterization and epitope mapping are slow, expensive and difficult to perform. We have developed a technology called Plasma Induced Modification to Biomolecules that addresses the need of the industry for routine structural, mass spectrometry-­based protein HOS analysis. PLIMB generates sub microsecond bursts of hydroxyl (OH) radicals from water to label proteins in solution. The OH radicals covalently labels the solvent accessible regions of the protein and subsequent mass spectrometric analysis reveals single amino acid level structural information. A way to quickly and efficiently analyze higher order structures of proteins on a benchtop scale, PLIMB will enable faster development of protein therapeutics, throughout the drug discovery process. In SBIR Phase I, we will prove the feasibility of a hydroxyl radical detection system that will tightly control the OH radical dose generated by PLIMB to yield highly reproducible HOS data. After completion of the SBIR Phase I project, we will continue the development and validation of the PLIMB system for commercial use. Ultimately, PLIMB will enable fast, high resolution structural analysis of proteins, a capability which is highly sought after in the pharmaceutical industry.

Public health relevance
Project Narrative The goal of this SBIR is to develop a highly reproducible, benchtop instrument to perform Hydroxyl Radical Protein Footprinting (HRF) for analysis of three-dimensional structures in protein therapeutics. This instrument will enable structural characterization of proteins at a much higher throughput than traditional techniques to better drive the discovery and development of protein therapeutics.